High throughput infrastructure for reaction screening and bioassays

High throughput infrastructure for reaction screening and bioassays
Mass spectrometry (MS) is a powerful and widely applicable analytical method for qualitative and quantitative
analysis of compounds of all types and sizes. Desorption electrospray ionization (DESI) is an ambient ionization
method in which samples are analyzed in the open air by impact of primary droplets. Given the ability to position
an array of samples relative to the mass spectrometer, DESI-MS becomes a high throughput (HT) chemical
analysis method. The power of MS as an analytical technique is well known but it is less commonly realized that
MS can also serve as a preparative method, e.g. it can be used to deposit mass-selected ions on surfaces to
create new materials in vacuo. Of significant interest to organic synthesis, a unique feature of DESI is that, upon
impact, the spray of solvent used to analyze a reaction mixture generates secondary microdroplets in which
reactions may be accelerated en route to the mass spectrometer. It is this remarkable feature that makes DESI-
MS a powerful synthetic method combined with a built-in analytical capability. With support of DARPA, we built
a high throughput system at Purdue capable of automated reaction screening at a rate greater than 1 reaction
mixture per second. We now propose an intramural - extramural collaboration between Purdue and the NCATS
ASPIRE laboratory. The UG3 component of the collaboration will focus on designing, fabricating, and testing an
improved high throughput system for reaction screening based on DESI-MS. The system will replicate the
capabilities of the existing Purdue system and also include new capabilities for small-scale synthesis combined
with high throughput bioassays. In the UH3 phase of the proposed study, the system will be transferred to NCATS
and used in collaboration with the intramural group. As an initial demonstration of the new high throughput
platform capabilities, we will pursue the discovery of novel therapeutics for advanced-stage prostate cancer, for
which current chemotherapeutic agents show limited effectiveness. Specifically, this effort will entail large-scale
screening and synthesis of potential cholesterol sulfotransferase (SULT2B1b, a currently undrugged biological
target) inhibitory compounds, together with late-stage functionalization of bioactive scaffolds to generate a
diverse range of analogs. Through this effort, the system will be established as an all-in-one next-generation
drug discovery platform, with integrated screening, synthesis, and biological assay capabilities. During the latter
stages of the UH3 phase, the versatility of the system will be tested in several other biological applications,
including directed evolution and functionalization of acetylcholinesterase reactivators. Successful completion of
these tasks will demonstrate the newly constructed high throughput DESI-MS platform to be an efficient method
for the discovery and expansion of chemical space towards currently undrugged biological targets.

Public health relevance
Project Narrative This study seeks to develop a high-throughput analytical and synthetic platform for drug discovery based on mass spectrometry. This technology will expand the capabilities of the NCATS ASPIRE laboratory, where it will provide unparalleled access to previously unexplored chemical space with potential to accelerate drug discovery. The newly developed system will be utilized to identify small bioactive molecules that target a key sulfate transfer enzyme involved in prostate cancer.